Activin type II receptor activity in age-related frailty and heart failure

PROJECT SUMMARY/ABSTRACT
The following proposal is submitted by Dr. Jason Roh, MD, MHS, in response to RFA-AG-19-017. Dr. Roh is a
cardiologist at Massachusetts General Hospital (MGH) and Instructor at Harvard Medical School (HMS). With a
combined interest in geriatrics, cardiology, and aging biology, he established the first geriatric-cardiology clinic
at MGH and has been investigating the role of aging in heart failure (HF). He is currently funded by an
American Heart Association Fellow-to-Faculty Award to study Activin type II receptor (ActRII) signaling in HF
and was recently recognized with American College of Cardiology and Northwestern Cardiovascular Young
Investigator’s Awards. Based on his prior research, Dr. Roh is proposing an innovative study with promising
translational potential that will focus on ActRII signaling in age-related frailty and HF. This proposal is based on
his preliminary data suggesting that catabolic ActRII signaling is altered by aging and directly contributes to HF
pathobiology. A strong association between advanced age, frailty, and cardiovascular disease (CVD) is well-
established. However, whether common biological mechanisms drive these age-related pathologies – and
importantly whether they can be effectively intervened upon – remain unclear. Here, Dr. Roh proposes a 4-
year program of career development and mentored research to achieve his long-term career goals of 1)
becoming a leading expert in aging biology in CVD and 2) developing novel therapies for heart disease in older
adults. Within the highly productive and supportive environment of the MGH Cardiovascular Research Center
and the HMS aging research community, he will work with his mentors, Drs. Anthony Rosenzweig, Lewis
Lipsitz, Jennifer Ho, and Dae Kim, on this integrated study spanning aging, frailty, and HF biology. The
overarching hypothesis is that increased ActRII signaling is causal in both frailty and HF pathobiology in older
adults, and that targeted ActRII inhibition can be used as a therapeutic strategy. The significance of this work is
highlighted by two major points: 1) HF is the leading cause of hospitalization amongst older adults, and 2)
there are currently no therapies that improve mortality in heart failure with preserved ejection fraction (HFpEF),
the leading cause of HF in older adults. Notably, the translational potential of this work is underscored by
ongoing clinical development of ActRII inhibitors for other indications (e.g. muscular dystrophy), which could
enable rapid translation of his findings. To achieve his goals, Dr. Roh will accomplish the following 3 specific
aims. Aim 1 is designed to determine if ActRII activity correlates with cardiac and frailty phenotypes and health
outcomes in older HF patients. Aim 2 expands on these findings in animal models to determine if ActRII
signaling is causal in age-related frailty and HFpEF. Lastly Aim 3, will use state-of-the-art single cell RNA
sequencing and molecular biology techniques to elucidate mechanisms by which ActRII signaling modulates
function in the aging heart and skeletal muscle. Completion of the proposed career development plan will
position Dr. Roh to successfully compete for NIA R01 funding and become a leader in cardiovascular aging.

Public health relevance
PROJECT NARRATIVE The proposed research seeks to elucidate the role of catabolic Activin type II receptor signaling in age-related frailty and heart failure. This research plan is relevant to public health because it is expected to lead to the development of novel therapeutics for heart failure, a leading cause of morbidity and mortality in older adults. Thus, it accomplishes the National Institute on Aging’s missions and initiatives by not only providing novel insights into the role of aging biology in a highly prevalent cardiovascular disease, but also potential therapeutic advancements that can improve the longevity and functional capacity in older adults.